Genomic, transcriptomic, and metabolic effects on skeletal health in Mexican Americans

PROJECT SUMMARY/ABSTRACT
Individuals with type 2 diabetes (T2D) have a 10%-30% higher risk of fractures than age-matched individuals
without T2D. However, the current paradox is that fragility fractures among people with T2D occur despite
apparently normal bone mineral density (BMD) measured by dual energy X-ray absorptiometry (DXA). Older
individuals with T2D have high fracture rates have low bone turnover, while high bone turnover increases the
risk of fracture in similarly aged non-diabetics. Currently available tools (BMD, markers of bone turnover) are
inadequate to screen or monitor bone health in individuals with T2D who have a high prevalence of fragility
fractures. Indirect measures of bone quality assessed from DXA images, the geometric parameters of the
femoral neck, and the lumbar spine Trabecular Bone Score (LS-TBS) has been recently associated with
fracture risk in older individuals. Identifying the best phenotype, genetic risk factors, and associated functional
changes is critical to detecting the earliest bone changes in older adults with T2D and the underlying metabolic
pathways leading to skeletal changes in participants with T2D. However, current research on skeletal health in
T2D is mainly gleaned from research in populations primarily of non-Hispanic Whites, even though Mexican
Americans (MA), the largest Hispanic/Latino (H/L) subgroup in the USA, have the highest prevalence of T2D
and osteoporosis. We propose to address these research gaps by leveraging our new and existing genetic and
phenotypic data on the population-based Cameron County Hispanic Cohort (CCHC) study using cross-
sectional and longitudinal designs. Our main goal is to investigate the causal pathways to bone loss and quality
and examine changes in metabolic and structural phenotypes in a sample of MA adults aged over 50 years.
The aims are to (1) Estimate the association of T2D on longitudinal changes in bone traits; (2) Identify
transcriptomic patterns associated with longitudinal changes in bone traits; and (3) Identify genetic
risk factors for bone traits, perform colocalization, and explore the causal role of T2D and metabolic
risk on bone quality via Mendelian randomization. We
expect
that
mechanistic insights into genetic and
transcriptomic factors associated with T2D and metabolic dysfunction that influence pathways leading to poor
skeletal health lead us to identify novel targets for early prevention and clinical intervention of osteoporosis and
fractures among older MA adults.

Public health relevance
PROJECT NARRATIVE Osteoporosis, associated fragility fracture, and type 2 diabetes (T2D) are major public health problems that disproportionately influence older Hispanic/Latino (H/L) populations. Using the integrative analysis of genetic and transcriptomic findings, the proposed study will identify causal pathways between T2D and metabolic risk and skeletal health among Mexican Americans, an understudied population. This study will offer better insights into skeletal health disparities in older H/L adults at risk for T2D to develop targeted interventions.